The Penn Center for Career Development in Women's Health Research

Project Summary
The Penn Women's Reproductive Health Research Career Development Program seeks continued support to
recruit, train, mentor and nurture the next generation of obstetrician-gynecologists destined for careers as
physician investigators and leaders in academic medicine. The program is designed to provide guidance and
support to Scholars to allow for the transition to productive, innovative and funded careers as independent
investigators. To accomplish our goal, we develop individualized research and career development programs,
utilize team mentoring, provide support for bioinformatics and biostatistics, and encourage participation in
courses in translational medicine and epidemiology, seminars, and specialized workshops to support academic,
research and leadership growth. The Penn WRHR Center builds on a tradition of multi-faceted investigation and
training in reproductive biology and women’s health in the Department of Obstetrics and Gynecology dating back
to 1964. The department and the Center for Research on Reproduction and Women’s Health are an integral part
of Penn’s exceptional biomedical research enterprise, ranking among the top in the nation, with numerous
clinical, basic, and translational research opportunities, outstanding research facilities, faculty and infrastructure,
and educational programs to foster the development of young physician investigators. With support from the
department chair and the School of Medicine, and guidance from the Research Director and teams of
experienced mentors from the department and relevant Centers and Institutes across the Penn campus, the
Scholars will advance their knowledge and research skills to be well-positioned to conduct independently funded,
innovative research in women’s health. The Penn WRHR Center has provided a mentored research experience
and career development program that has inspired our Scholars to remain in academic medicine and establish
highly productive, funded research programs. Of the 13 Scholars enrolled in the program, 11 have completed it
and 2 currently are active. The 11 graduates all have an exemplary record of scholarship, research productivity
and funding, promotion and leadership in academic medicine. They have received a total of 27 federal grants
including 7 R01s and 2 R01-equivalents as well as foundation grants, and are serving as members of NIH study
sections and editorial boards, and in leadership positions at their respective institutions and professional
organizations. The Penn WRHR Center’s philosophy, approach, and ability to provide a supportive environment
that embraces trans-disciplinary investigation and discovery will continue to prepare Scholars for careers as
physician investigators and leaders in academic obstetrics and gynecology.

Public health relevance
Project Narrative The Penn WRHR Center will encourage and foster the development of academic obstetrician gynecologists in order to contribute to the improvement of the health of women and their children.